A pilot study of fenofibrate to prevent kidney function loss in type 1 diabetes

SUMMARY
Despite improvements in the past 20 years in glycemic and blood pressure control, and the introduction of
“reno-protective” drugs such as renin-angiotensin system blockers (RASB), the overall incidence of end-
stage kidney disease (ESKD) in type 1 diabetes (T1D) remains high. To seek new treatments to prevent
diabetic kidney disease (DKD) and/or slow its progression to ESKD in T1D, we have established a unique
consortium of high-quality academic centers, which we have named PERL (Preventing Early Renal Function
Loss in Diabetes) to emphasize the focus on intervening relatively early in the course of DKD in T1D, when
renal damage can more likely be slowed or stopped. Findings from the FIELD and ACCORD trials suggest a
reno-protective effect of the PPAR-alpha agonist fenofibrate, raising the exciting possibility of using this
inexpensive generic drug to prevent GFR decline in persons with T1D. These data, however, were obtained
through post-hoc analyses of T2D populations with clinical characteristics optimized for CVD studies. Thus,
a clinical trial specifically designed to evaluate effects on GFR decline is required to firmly establish a DKD
indication for fenofibrate in T1D. As a first step, and in response to FOA PAS-20-160 “Small R01s for clinical
trials targeting diseases within the mission of NIDDK”, we have designed a pilot study including 40
participants with T1D and early-to-moderate DKD, at high risk of ESKD, who will be enrolled at two of the
PERL sites and randomized in a 1:1 ratio to treatment with fenofibrate or placebo for 18 months. Through
this pilot study we will: 1. Define the nature of the acute effect of fenofibrate on kidney function. It
remains unclear whether the eGFR reduction observed at the beginning of fenofibrate treatment is an
artifact of fenofibrate-induced changes in creatinine production and/or renal tubular handling, or corresponds
to an actual reduction in GFR. We will resolve this controversy, which has crucial implications for the pivotal
trial design, by directly measuring GFR by plasma iohexol disappearance – a methodology in which PERL
sites are experienced. 2. Generate further data on the long-term effects of fenofibrate on GFR decline
in persons with T1D and DKD who are at high risk of rapid GFR decline and ESKD. The positive
effects of fenofibrate in FIELD and ACCORD were observed in individuals who were not selected for having
DKD and who, if untreated, had a mean GFR decline barely above the physiological decline due to aging.
To make a compelling case for a pivotal trial for kidney outcomes, it is crucial to generate preliminary data
on the effectiveness and safety of this drug in persons selected for having DKD and being rapidly
progressing towards ESKD. 3. Determine the effects of fenofibrate on biomarkers of increased risk of
fast GFR decline. A salutary effect of fenofibrate on one or more of these biomarkers will corroborate any
trend of a fenofibrate benefit identified in Aim 2. With the results of this pilot, we will be optimally prepared to
apply to NIDDK for support of a pivotal trial to establish a kidney indication for fenofibrate in T1D.

Public health relevance
NARRATIVE This pilot study is essential for the design of a pivotal clinical trial evaluating the generic drug fenofibrate as a reno-protective agent in patients with T1D. If this study eventually leads to the development of a new intervention to prevent or delay of ESKD, the reduction in morbidity and mortality resulting from this would have a major impact on the lives of T1D patients as well as on society at large, significantly reducing the human and financial costs associated with diabetic kidney disease.